The role of central amylin receptor in opioid-mediated behaviors

Project Summary
The opioid epidemic remains a major public health crisis in the U.S. Despite the effectiveness of current FDA-
approved medications to treat opioid use disorder (OUD), there is still a high rate of relapse following
detoxification. Thus, there is a critical need for conceptually new research investigating the neurobiological
mechanisms underlying opioid taking and seeking that could lead to novel druggable targets. Our exciting
preliminary studies indicate that systemic infusions of amylin, a satiation factor and neuropeptide, attenuate
oxycodone self-administration and reinstatement at doses that do not alter food intake or compromise the
antinociceptive effects of oxycodone. Consistent with these findings, activation of amylin receptors in the
mesolimbic reward system is sufficient to reduce oxycodone self-administration and reinstatement. While our
pilot studies highlight a novel neuropeptide system that could be targeted to reduce opioid taking and seeking,
there are significant gaps in our understanding of central amylin receptors and their role in addiction-like
behaviors. We recently began to identify cell type-specific patterns of amylin receptor expression in the brain
and showed that amylin receptors are expressed on dopamine and GABA neurons in the ventral tegmental
area (VTA), as well as dopamine d1 receptor (D1R) and dopamine d2 receptor (D2R) -expressing medium
spiny neurons (MSNs) in the nucleus accumbens (NAc). One goal of this proposal is to build upon and expand
our pilot studies by comprehensively defining the functional roles of cell type-specific VTA and NAc amylin
receptors in opioid taking and seeking using viral-mediated methods in transgenic rats (Aim 1). We will also
determine the individual contributions of these amylin receptor-expressing cell types to amylin's efficacy (Aim
1). Very little is known about the cellular and molecular mechanisms underlying the suppressive effects of
amylin pharmacotherapy on voluntary drug taking and seeking. Therefore, we will combine viral-mediated gene
delivery approaches with in vivo fiber photometry in transgenic rats to determine how amylin pharmacotherapy
alters intracellular calcium dynamics in specific VTA and NAc cell types of oxycodone-experienced and drug-
naïve rats in order to understand how activation of central amylin receptors alters midbrain and striatal circuits
to suppress opioid taking and seeking (Aim 2). Finally, we will use an unbiased, single nuclei transcriptomics
approach to characterize the effects of oxycodone alone and in combination with amylin pharmacotherapy on
amylin receptor expression and differently expressed genes (DEGs) in all VTA and NAc cell populations (Aim
3). Findings from these studies will provide our first insights into how oxycodone alters amylin receptor
expression and signaling in specific midbrain and striatal cell populations and identify opioid dysregulated
genes that are putatively restored by amylin pharmacotherapy. Overall, the research proposed in this
application will advance a novel framework for the development of pharmacotherapies aimed at targeting
central amylin receptor-expressing cells to treat OUD.

Public health relevance
Project Narrative The ultimate goal of these experiments is to identify novel pharmacotherapuetic approaches to treating opioid use disorder (OUD). Using rodent models of OUD, our pilot studies indicate that activation of amylin receptors in the brain is sufficient to attenuate voluntary opioid-taking and -seeking behaviors. These findings provide strong rationale for clinical studies examining the efficacy of amylin analogs to reduce OUD and support drug development strategies aimed at increasing amylin receptor signaling in the brain to selectively attenuate opioid-mediated behaviors.